CRYSTALLOGRAPHIC STUDIES OF MEDICALLY INTERESTING PROTEINS

0.2 mm crystals have been obtained from fragment of a viral protein. They can be frozen and we would collect cryo data. Data can be collected at about I hr / 0.5 degree oscillation in house (Raxis IV). We seek to collect better quality data, both native and derivative. Derivative investigation is currently underway in house, and we would anticipate collecting derivative data as well. To date merging statistics are not good enough to give confidence in MAD phasing. Data was collected on BioCARS Station 14 BM-C.